The impact of T cell selection on vaccine durability

Project Summary
An ongoing outbreak of a novel coronavirus infection (COVID-19) has claimed millions of lives and disrupted
social infrastructures around the world. Fortunately, the new mRNA vaccines from Moderna or Pfizer/BioNTech
are highly effective against SARS-CoV-2. However, much remains unknown about the longevity of memory
responses generated by the new mRNA-based vaccine platform in humans. With the emergence of new viral
variants, there is also the need to have a flexible type of immunologic memory that is not only long-lasting but
can also respond to mutated viruses. My lab studies human T cell memory. We have shown that the human
pre-immune T cell repertoire for a novel pathogen is shaped by past antigen experiences and contains cross-
reactive memory T cells that could compete with naïve T cells. Using a highly effective live attenuated yellow
fever virus (YFV) vaccine as a model for novel infectious challenge, we tested how pre-immune repertoire
impacts post-vaccine response. Multiple YFV-specific populations were identified longitudinally within the same
individual using peptide-MHC (pMHC) tetramers. Extensive single-cell T cell receptor (TCR) sequencing on
tetramer+ cells was used to follow progenies of the same parent cells over time. We found that vaccine
selectively recruits initially rare but more responsive T cells, leading to better repertoire fitness and higher TCR
diversity after vaccination. Having a diverse TCR repertoire has been directly linked to protective T cell
responses and host survival in mice. For fast evolving pathogens, the diversity in T cell composition may
additionally limit escape variants as mutations emerge. Here, we will use the mRNA vaccines for COVID-19
(COVID vaccines) as a model to study the durability and the breadth of T cell responses elicited by mRNA-
based vaccine strategies. We hypothesize that effective peripheral T cell selection is critical for
maintaining durable immunity against actively mutating viruses. Here we will build on established
biological insights, resources, and donor recruitment infrastructures to determine: (1) if COVID vaccine drives
effective repertoire selection and diversification, (2) how boosting enhances CD4+ T cell diversity and variant
recognition, and (3) how post-vaccine memory cells are maintained and change with time. The proposed
experiments will map the entire trajectory of vaccine-induced response using precise molecular and cellular
tools. Data from this study will provide vital knowledge on the quality, the breadth, and the longevity of CD4+ T
cell response to the mRNA vaccines in humans. Beyond COVID, insights revealed by the proposed research
will be relevant for understanding how immunological memory is generated and preserved. The proposed
research will therefore have broad impact and could aid future development of improved vaccine strategies for
other pathogens.

Public health relevance
Project Narrative Very little is known about immunological memory to COVID vaccines. The proposed study investigates how useful T cell memory is formed and maintained. These data will provide critically needed information on human T cell response to the new mRNA vaccines and uncover novel insights that may enable better immunization strategies in the future.